Core B: Omics and Bioinformatics Core MSU COBRE Phase II

Project Summary
The Center of Biomedical Research Excellence (COBRE) Phase I, Pathogen-Host Interactions at Mississippi
State University (MSU) successfully incorporated the MSU Institute for Genomics, Biocomputing and
Biotechnology (IGBB) as part of a systems biology Core B. Core B services provide access to expertise,
instrumentation, biocomputing and bioinformatics necessary for generating and analyzing high throughput omics
data. The goals of the Omics and Bioinformatics Core B in this COBRE Phase II application are to 1) build on
the technical and intellectual infrastructure gains made in COBRE Phase I, and 2) continue to provide service
and expertise in an effective and responsive manner to meet the critical needs of COBRE Phase II Lead
Investigators. To expand omics capabilities at MSU to meet COBRE Phase II investigator needs in
metabolomics, we propose to integrate the existing instrumentation and resources at MSU from different
departments and institutes (located physically within a mile) into a ‘virtual’ Omics and Bioinformatics Core (Core
B). Therefore, the Objective of Core B is to continue integrating and building on existing equipment and personnel
into the COBRE atmosphere not only to make access more efficient for COBRE investigators but also to
stimulate biomedical research at MSU in general. This will be accomplished through three specific aims: 1.
Provide an administrative mechanism to ensure COBRE investigators access to instrumentation, and expertise
for conducting omics research, such as proteomics, RNA-Seq and metabolomics as well as biocomputing and
bioinformatics. 2. Enhance existing infrastructure, stability, and sustainability of omics technologies required for
COBRE projects. 3. Provide technologies and analytical support required by Phase II COBRE investigators.
Omics and Bioinformatics Core B will make significant contribution towards COBRE sustainability as it provides
services in genome scale technologies that are at the forefront of the biomedical research enterprise. COBRE
Phase II Core B will build on the success in of Phase I and enable COBRE Investigators to develop the thematic
multidisciplinary research focus into a functioning, productive biomedical research center.

Public health relevance
Project Narrative The goal of the COBRE Phase II Omics and Bioinformatics Core B is to help Lead Investigators to address infectious disease research questions utilizing omics techniques and bioinformatics resources and biocomputing to generate novel biological insights. Successful completion of the three specific aims will ensure that the primary Objective of Core B is met. That is, Core B will serve to integrate and enhance existing equipment and personnel into the COBRE atmosphere to make access more efficient for COBRE Investigators and to stimulate biomedical research at MSU in general.